Glyconjugate Analysis Workshop

[unreadable] DESCRIPTION (provided by applicant): Glycobiology has become increasingly important as carbohydrates are found to play important roles in various biological processes such as antibody recognition, cell-cell adhesion, and tumor metastasis. Currently, many diverse methodologies are employed in carbohydrate sequencing. In addition, the notion of how much empirical information is required to determine a structure is still a topic of contentious debate. The purpose of the "Charles Warren Workshop on Glycoconjugate Analysis" is to bring together experts in the field of carbohydrate structural analysis in order to discuss the various methodologies currently in use. The aim of this conference is to provide researchers with sensitive and comprehensive analytical strategies that account for all aspects of oligosaccharide structure. The goal of this conference is to bring unanimity to the diverse methodologies currently employed in carbohydrate sequencing. The growing needs in glycobiology for glycoconjugate structural analysis as well as automation of methods and high throughput analysis make open discussion among experts very timely and important. These discussions among experts in the discipline will hopefully lead to establishment of a working framework and course of action to bring uniformity to the goals and requirements of glycoconjugate structural analysis. To that end, four broad topics of discussion are proposed: detailed structure analysis, high throughput analysis, glycoproteomics and glycolipidomics, and bioinformatics. Discussion sessions will allow experts to compare and contrast different views and methodologies. From these discussions, it is hoped that a comprehensive strategy for carbohydrate sequencing can be formulated. [unreadable] [unreadable] [unreadable]